Vitamin D to Prevent Severe Asthma Exacerbations in High-Risk Children - CCC

? DESCRIPTION (provided by applicant): Findings from observational studies by our group and others suggest that vitamin D insufficiency (a common condition) is associated with an increased risk of severe asthma exacerbations in school-aged children. We hypothesize that vitamin D supplementation reduces the incidence of severe asthma exacerbations in high-risk (so defined due to an exacerbation in the previous year) children aged 6 to 14 years who have vitamin D insufficiency (a serum 25(OH) D <30 ng/ml) and who are being treated with inhaled corticosteroids (ICS) for mild to moderate persistent asthma. We further hypothesize that this protective effect results from a reduced incidence of viral infections that lead to severe asthma exacerbations and/or enhanced response to ICS in these children. We will test this hypothesis in a randomized double-masked placebo-controlled clinical trial with the following primary and secondary Specific Aims: Primary Specific Aim 1) To determine whether vitamin D3 supplementation (4,000 IU/day) is superior to placebo in preventing severe asthma exacerbations in high-risk school-aged children who have vitamin D insufficiency and who are on ICS for mild to moderate persistent asthma. Secondary Specific Aims In high-risk school-aged children with vitamin D insufficiency who are on ICS for asthma, to determine whether vitamin D3 supplementation is superior to placebo in: 1) Preventing severe asthma exacerbations resulting from viral infections 2) Reducing the daily dose of ICS as well as the average cumulative dose of ICS, at the end of the trial

Public health relevance
PUBLIC HEALTH RELEVANCE: Identifying new strategies to prevent severe asthma exacerbations would have a major impact on clinical practice and public health. This application will determine whether high-dose vitamin D supplementation should be recommended as adjuvant therapy to inhaled corticosteroids for high-risk school-aged children with mild to moderate persistent asthma and vitamin D insufficiency. To accomplish this goal, we have assembled a research team with expertise in asthma epidemiology, vitamin D and asthma, and clinical trials.